Development of early metabolic imaging biomarkers for muscular dystrophy and cardiomyopathy in patients

PROJECT SUMMARY/ABSTRACT
Dystrophinopathy is a group of X-linked neuromuscular disorders, resulting from mutations in the dystrophin
genes. Duchenne muscular dystrophy (DMD) and a milder form, Becker muscular dystrophy (BMD), are the
most common forms of dystrophinopathy. Both types of muscular dystrophy (MD) patients develop progressive
wasting of skeletal muscle and heart failure, and currently there is no absolute cure. Despite extensive
investigation into the management of MD, tools for monitoring the disease progression and the treatment
response are yet to be established. Mitochondrial dysfunction and inflammation are indicative metabolic
phenotypes of the severity of dystrophinopathy and precede muscle damage, playing causative roles in the
pathogenesis of MD. Patients with MD have decreased level of glucose in the skeletal muscle and the
myocardium, contributing to the low concentration of downstream metabolites and the subsequent energy
deficiency in the muscle. However, how the myocytes utilize the fuel is underexplored. Pyruvate, the end-product
of glycolysis, is positioned at a unique metabolic junction that can witness both mitochondrial dysfunction and
inflammation via two enzymatic reactions: PDH and LDH. Pyruvate dehydrogenase (PDH) links glycolysis and
the tricarboxylic acid (TCA) cycle in mitochondria. Lactate dehydrogenase (LDH) activity is often considered as
a measure for glycolysis or anaerobic respiration and is positively correlated with tissue inflammation. Carbon-
13 (13C) MRI with an intravenous bolus injection of hyperpolarized (HP) [1-13C]pyruvate is a unique imaging
method for estimating LDH activity and PDH flux by the in-vivo products, [1-13C]lactate and [13C]bicarbonate,
respectively. Since hyperpolarization technology is using stable isotope (no ionizing radiation) and pyruvate is a
natural metabolite, it is safe to inject HP [1-13C]pyruvate into both adult and pediatric patients. In this proposal,
we will investigate mitochondrial dysfunction and inflammation in DMD and BMD patients using HP [1-
13C]pyruvate MRI. Thus, the overall goal of the study is to develop non-invasive biomarkers that detect early
metabolic changes associated with myopathies in patients with MD. The underlying hypothesis is that
metabolic alterations in myocardium and skeletal muscle precede myopathies associated with
dystrophinopathy. The specific aims include to develop elevated lactate production as a biomarker for
myocarditis and skeletal muscle inflammation (Aim 1), to develop limited bicarbonate production as a biomarker
of mitochondrial dysfunction (Aim 2), and to assess early changes in lactate-to-bicarbonate ratio in predicting
MD-associated myopathy (Aim 3). The imaging biomarkers will be compared to clinical cardiac parameters (e.g.,
ventricular ejection fraction) and other inflammatory markers or coronary risk indicators from blood samples (e.g.,
high-sensitivity troponin T). The research outcome of the proposed study will develop in-vivo imaging biomarkers
that assess metabolic characteristics of the heart and skeletal muscle in patients with muscular dystrophy, and
set a groundwork for clinical translation of this technique to muscular dystrophy patients.

Public health relevance
Muscular dystrophy is a genetic disorder that develops progressive wasting of skeletal muscle and heart failure. Metabolic phenotypes precede muscle wasting and have been targeted for mechanistic understanding and development of therapeutic intervention, yet their roles in pathogenesis of muscular dystrophy are still unclear. In this study, we will develop non-invasive imaging biomarkers that describe two major metabolic phenotypes of muscular dystrophy: inflammation and mitochondrial dysfunction.